University of Rochester CTSA Hub

The University of Rochester Clinical and Translational Science Institute (CTSI) is the clinical and translational research engine of the University of Rochester Medical Center. Over the last 19 years, the CTSI has catalyzed translational research across the university, building a robust clinical and translational science ecosystem. Our mission is to accelerate the translation of discoveries to clinical therapies and population health, with impactful and measurable outcomes at local and national levels. We pursue that mission through innovative translational science, leveraging our deep expertise in informatics, community engagement, workforce development, clinical trials, population health research, ethics, and our extensive national engagement. The CTSI framework for translational science is embodied in our overarching theme of “Research Without Walls”. We work closely with our external partners and collaborators to move beyond the physical and virtual confines of institutions and translational barriers, to accelerate discovery. During this next project period, we will organize around two major themes: 1) Translational Science (TS), removing translational barriers by using cutting-edge informatics, innovative translational artificial intelligence/machine learning (AI/ML) solutions, and accelerating clinical trials, and 2) using TS to improve health for all through community-engaged research, shared values and priorities, and decreasing barriers to access and implementation in translational research. These efforts will speed the translation of novel therapeutics, AI/ML tools, and discoveries to improve health for all people. Our specific aims address specific translational barriers and support Research Without Walls: (1) Advance translational science (TS) by catalyzing the development, dissemination, and implementation of innovative and impactful research. The UR CTSI will grow our comprehensive program in TS as a rigorous and independent discipline, focusing on measurable impact. (2) Accelerate Translational Research for all stakeholders, and improve health for all populations, by working with our collaborators, our learning healthcare system, community, and stakeholders. Building on our extensive community engagement programs, we will expand community-driven research with a focus on improving health for all. (3) Advance innovative informatics and analytics to improve the speed, rigor, and reproducibility of clinical and translational research. (4) Equip a talented translational science workforce with tools to speed the translation of discoveries to clinical application with innovative TS training across the TR workforce; and (5) Collaborate across the CTSA Consortium to rapidly respond to evolving national research and public health priorities and emergencies. Our CTSI has tight integration of population health research, basic and clinical research data and analytics, training programs for a skilled translational research workforce, implementation science programs, community engagement and collaboration, and regulatory science methods for the digital era, supporting our ability to improve health for all.

Public health relevance
The University of Rochester Clinical and Translational Science Institute (CTSI) is the clinical and translational research engine of the University of Rochester Medical Center. Our mission is to accelerate the translation of discoveries to clinical therapies and public health in order to bring more therapies to all people, more quickly. We do this through innovative translational science, deep expertise in health informatics and artificial intelligence methods, community partnerships, research training, clinical trials, population health research, research ethics, and working with partners across the country.